Receptor Crosstalk in HNSCC Metastatic Progression

The insulin-like growth factor 1 receptor (IGF1 R) is an essential regulator of cell growth and transformation, that promotes tumor cell proliferation, motility and protection from apoptosis. We have shown that in oral squamous cell carcinoma (OSCC) cells IGF1 R activation increases vascular endothelial growth factor (VEGF) synthesis and secretion, initiating an autocrine VEGF:VEGFR2 signaling loop. Our overall hypothesis stipulates that VEGF signaling via VEGFR2, leads to enhanced OSCC tumorigenicity and invasive cell behavior. In strong support of this hypothesis we have used a phosphotyrosine proteomics screen and identified a cluster of proteins involved in cell motility that is activated by VEGF stimulation. These proteins include human enhancer of filamentationi (HEF1), cortactin, paxillin, and focal adhesion kinase. Of significance, HEFI has been identified as a signature protein required for metastasis in melanoma, glioblastoma and breast cancer. The goal of AIM I is to define the mechanism through which HEF1 mediates VEGF induced OSCC cell migration and invasion. To this end, we will define the specific tyrosine residues in HEF1 that are phosphorylated in response to VEGFR2 activation using complementary biochemical techniques and site-directed mutagenesis. In AIM 2 we will define VEGF regulation of invadopodia formation and the structural and functional contributions of HEFI to this process. As a subset of this aim we will examine HEFI localization to invadopodia and what domains on HEF1 enable its association with invadopodia. These studies should provide important evidence demonstrating a role for HEFI in OSCC metastatic signaling downstream of crosstalk to VEGFR2. They will lead to the development of novel strategies and therapeutic agents aimed at reducing the tumorigenic and metastatic effects of the IGF and VEGF pathways in OSCC.

Public health relevance
Cancer of the head and neck is the 6th most frequently occurring cancer worldwide, causing nearly 8,000 deaths per year nationally. Alcohol and tobacco are common risk factors, but additional factors contribute, including the IGF system and as shown here, VEGF signaling pathways. This proposal seeks to define the mechanisms through which VEGF receptors regulate the invasive and metastatic behavior of head and neck squamous cell carcinoma.